Linking substance use genetics to circadian function using high-throughput genomics

SUMMARY
Substance use disorders, including opioid use disorder, are rising across the United States have
devastating consequences on those affected as well as their family and friends. There is growing
evidence that addiction and sleep are tightly linked at the genetic, molecular, and behavioral
levels. At the genetic level, there have been hundreds of loci confidently linked with addiction
phenotypes and sleep phenotypes. Genetic variants associated with both sleep and addiction
show enrichment in distal open chromatin regions of many of the same striatal neuron subtypes.
Despite these associations, it remains unexplored whether genetic variants that impact the
predisposition to addiction or sleep phenotypes also directly impact the circadian regulation of
gene expression. The difficulty in understanding the gene regulatory mechanisms underlying
candidate addiction- and sleep-associated genetic variants results from an inability to perform
controlled experiments in an intact human brain. Here, we leverage a combination of machine
learning and genomic technologies to make inferences about how genetic variants impact the
circadian regulation of gene expression by altering the combinatorial code of transcription factors
at distal enhancer regions. In Aim 1, we conduct controlled single cell genomic experiments in the
mouse striatum, which serve as training data for convolutional neural network models. These
models then make inferences across the entire human genome about which genetic variants are
likely to modulate circadian gene regulation. In Aim 2, we synthesize hundreds of candidate
human addiction- and sleep- associated enhancers and then measure their circadian regulation
in in vivo massively parallel reporter assays conducted in the mouse striatum. In Aim 3, we apply
comparative genomics to find enhancers that are likely to be conserved in function between
human and mouse. The result of disrupting those enhancers in a CRISPR-KRAB mouse strain is
measured using a variety of behavioral assays for addiction and sleep phenotypes. The result of
these aims will be predictions and measurements of the circadian function across hundreds of
enhancers that contain addiction- and sleep-associated genetic variants. These experiments will
allow us to test the hypothesis that addiction-associated genetic variants impact predisposition by
influencing circadian gene regulation. More broadly, we will provide a framework to understand
the genetic mechanisms of addiction and sleep across other brain regions and tissues as well as
in other disease contexts.

Public health relevance
NARRATIVE Human genome wide association studies have found hundreds of loci that influence the predisposition to addiction behavior, sleep behavior, or both. Although circadian rhythms have been tightly linked to addiction and sleep, limitations in studying humans directly have led to difficulties in elucidating how differences in genetics lead to differences in circadian gene regulation and addiction behavior. Here, we overcome those limitations by combining high throughput genomic experiments in mice across times of day with predictions across the human genome made by machine learning models.